Targeting metabolism to improve outcomes following severe influenza infection

Targeting Metabolism to Improve Outcomes following Severe Influenza Infection
Brydie Huckestein
Advisor: Dr. John Alcorn
Program in Microbiology and Immunology, University of Pittsburgh
ABSTRACT
Widespread epithelial damage in the lungs is a hallmark of influenza infection. Our laboratory and others have
shown that influenza infected mice have persistent lung damage, inflammation, and epithelial metaplasia up to
60 days post-infection. In humans, alveolitis can persist for years following an influenza infection. I hypothesize
that treating mice with metabolism-targeting medications will improve lung repair following influenza infection by
reducing inflammation and promoting alveolar regeneration. Epithelial metaplasia following influenza infection
reduces lung function and is caused by undifferentiated lineage negative epithelial progenitor cells (LNEPs).
Preliminary data indicates LNEPs have increased activation of the energy sensing kinase mammalian target of
rapamycin complex 1 (mTORC1) 21 days following influenza infection. Studies in other stem cell populations
show that mTORC1 activation can inhibit differentiation into mature cell types, but its role in LNEP differentiation
is unknown. I propose that treating mice with the mTORC1 inhibitor rapamycin two weeks following influenza
infection will promote differentiation of LNEPs into AT II cells and reduce the presence of epithelial metaplasia.
Additionally, preliminary data suggests oxidative stress is occurring in the lungs 21 days following influenza
infection. Ingenuity Pathway Analysis shows that macrophage ROS production is increased in the mouse lung
at this time, and high resolution respirometry data indicates increased oxidative phosphorylation. I propose that
treating mice with metformin, an AMPK activator, will reduce oxidative stress during lung repair following
influenza infection. The following studies will determine how rapamycin and metformin impact inflammation and
cellular repair mechanisms in the lung during the recovery phase following severe influenza infection. The goal
of this project is to determine if metabolism targeting medications can be repurposed to treat patients who
continue to suffer after their viral respiratory infection has been cleared.

Public health relevance
PROJECT NARRATIVE A single, severe influenza infection can result in long-lasting inflammation and lung impairment, yet influenza therapies primarily target the acute stage of disease. Rapamycin and metformin are both approved medications that target cellular metabolism. I propose that treating mice with rapamycin or metformin will reduce inflammation and promote lung repair following clearance of a severe influenza infection.